Quantification and automated characterization of mucus plug pathology in asthmatics

Project Summary
Mucus plugging has long been implicated in acute and fatal respiratory events in severe asthma, but we have
recently shown that chronic mucus plugging is common in asthmatic patients and appears mechanistically
linked with both impaired airflow and worsening disease severity. In particular, in analyses of baseline
computed tomography (CT) lung scans in asthmatic patients, we found that airway mucus plugs are highly
prevalent, persist for many years, frequently occur without cough and sputum symptoms, and are strongly
associated with airflow obstruction. However, it is unknown what radiographic characteristics of mucus
plugging cause severe airflow obstruction, in part because detailed characterization of mucus plugs on CT
scan is extremely labor intensive and requires highly trained thoracic radiologists for assessment. In Aim 1 of
this application, we propose to test the hypotheses, informed by our preliminary data, that three radiographic
features of mucus plugs— mucus plug volume, number of proximal plugs, and fraction of airway tree occluded
—all predict worsening airflow obstruction. We additionally propose that the airway tree can be converted into
a network of resistive elements in which the effective resistance of the entire tree is computed with and without
mucus plugs, and the relative contribution of mucus plugs to airway resistance can be determined. In Aim 2,
we aim to substantially lower the barrier to quantification of mucus plugging on CT scans by developing an
automated, convolutional neural network-based algorithm for mucus plug segmentation. We believe that our
findings will allow the identification of a large subset of patients with chronic severe “mucushigh” asthma and
raise possibilities for novel mucus-targeted treatments to improve airflow and other disease outcomes in this
subset of patients.

Public health relevance
Project Narrative We hypothesize that chronic mucus plugging plays an important role in airflow obstruction in asthma and that detailed characterization of radiographic features of these plugs will identify a subset of patients who may respond to mucus-directed therapeutics. We believe that the detailed characterization required to identify these patients can be automated using state-of-the-art artificial intelligence techniques in order to allow widespread implementation of these novel diagnostic methods.